Modular, degradable, polymeric nanoparticles for the treatment of phagocyte-mediated diseases

PROJECT SUMMARY/ABSTRACT
Nanoparticle (NP) drug delivery systems enable the protection of therapeutic cargoes with tunable target
specificity. Polymeric NPs exhibit phagocytic tropism, accumulating in the reticuloendothelial system of the liver
and spleen. This property is a barrier to non-phagocyte drug delivery but a boon for the development of
phagocyte-mediated disease therapies. We have developed a highly tunable, biodegradable NP platform
composed of poly(amine-co-ester) (PACE) polymers that has been successfully utilized to deliver nucleic acids
to various tissues. We have demonstrated that NP design and administration variables dictate the organ and
cellular biodistribution of PACE NPs. How these variables dictate biodistribution to specific phagocyte
subpopulations and how these principles are modulated in the presence of phagocyte-mediated disease are
unknown. This proposal outlines a four-year training program for Dr. Thomas C. Binns, MD – enabling his
development into an independent investigator with expertise in understanding NP-phagocyte interactions with
the goal of developing novel drug delivery approaches for the treatment of phagocyte-mediated diseases.
Dr. Binns will study how PACE NP design/administration principles influence uptake in hepatic and splenic
phagocyte subpopulations during health and disease. The most important NP design variables – size, charge,
stiffness, surface hydrophobicity, and dose – will be evaluated, as we have previously demonstrated that these
variables influence biodistribution on the organ and cellular scales. Dr. Binns will carry out these investigations
in established murine models of health (Aim 1) and antibody-mediated erythrophagocytosis (AME; Aim 2). This
work addresses an area of unmet medical need: AME defines several diseases including warm autoimmune
hemolytic anemia, a disease with an estimated 40,000 patient US prevalence, 50% relapse rate, and 10%
mortality. A novel treatment option with a long duration of activity and/or a lower drug-mediated morbidity profile
could significantly change the therapeutic paradigm for patients with relapsed/refractory disease. Findings will
be leveraged to develop a preclinical nucleic acid therapeutic for AME facilitated by PACE NP delivery (Aim 3).
Dr. Binns has assembled a team of experts in polymer synthesis, NP formulation, nucleic acid therapeutic
design, antibody-erythrocyte interactions, and phagocyte biology/phenotyping who will provide experimental
insights, technique advisement, and career mentorship. He will gain training in polymer synthesis,
sophisticated data acquisition and analysis (e.g., highly-multiplexed flow cytometry), drug
development/translation, and laboratory management in an environment conducive to training physician-
scientists. These skills will enable Dr. Binns to successfully transition to an independent position with the goal
of developing drug delivery approaches for the immunomodulation of phagocytes.

Public health relevance
PROJECT NARRATIVE Phagocyte-mediated processes and diseases are highly relevant to the practice of transfusion medicine as well as to the broader field of medicine. Poly(amine-co-ester) (PACE) nanoparticles exhibit phagocytic tropism and possess a demonstrated capacity to deliver therapeutic nucleic acids – both properties positioned to offer novel, paradigm-shifting treatment options to patients with phagocyte-mediated diseases. This work will determine how PACE nanoparticle design, composition, and administration influences drug biodistribution to phagocyte subpopulations in the liver and spleen in health and disease and leverage these findings to develop a novel therapeutic for antibody-mediated erythrophagocytosis, a phagocyte-mediated disease that subjects patients to high morbidity, mortality, and transfusion burden despite current off-label therapies.